University of Pittsburgh Clinical and Translational Science Institute

PROJECT SUMMARY/ABSTRACT
Patient portals are secure, online health management tools that connect patients to portions of their electronic
health record and serve as the entry point for digital care in 90% of health systems. For children (0-12 years
old), the patient portal is accessed by a parent or caregiver acting on the child's behalf. Geographic, financial,
communication, and structural barriers that limit access to in-person care can create barriers to digital care.
Inequities in portal enrollment and use may disproportionately affect children who also face limited access to
in-person care, exacerbating disparities. As the patient portal is designed as the entry point for digital
engagement with healthcare, it is essential to understand the factors leading to inequitable enrollment in order
to promote equitable access to digital healthcare for all children. The overall goal of this study is to identify
strategies to align pediatric patient portals with the expectations and needs of parents to enhance use and to
ultimately improve health communication and equitable child health outcomes. In Aim 1, we will examine
child, family and system-level factors associated with proxy enrollment in and use of a pediatric patient portal
among children receiving care across >125 primary care practices. In Aim 2, we will conduct semi-structured
interviews with caregivers who are not enrolled in a pediatric patient portal to explore expectations, and
challenges regarding patient portals. With committed mentors and strong institutional support, the PI will
receive mentorship, didactic education and research experience for her career development in equity-
centered research methods, qualitative methods, and leadership skills, thus preparing her for a K23 application
to launch a career as an independent health services researcher focused on improving child health outcomes
through equitable and appropriate application of technology.

Public health relevance
PROJECT NARRATIVE Technology-enabled care, including care delivered via patient portal, e-consult, and telemedicine, has the potential to overcome many known barriers to receiving in-person healthcare including transportation and logistical barriers. The patient portal is designed to be the entry point to accessing technology-enabled care and therefore is a critical focus to ensure equitable ability to access and utilize technology-enabled care, yet work is necessary to ensure equitable access and engagement with the patient portal in pediatrics. By studying access, use, and engagement with the patient portal in pediatric primary care, this proposal will directly inform efforts to improve access and outcomes for children in need of healthcare.